Oncolytic Herpes Simplex Virus Interactions with Glioblastoma Stem Cells

? DESCRIPTION (provided by applicant): Glioblastoma (GBM) is a primary brain tumor with a five year survival rate of about five percent. While searching for the cells which initiate GBM tumors, researchers isolated glioblastoma stem cells (GSCs). Implanting a low number of these cells into immunocompromised mice yields a lethal tumor which resembles the pathology of the patient's tumor from which the cells were isolated. Oncolytic herpes simplex viruses (oHSV) selectively kill brain tumor cells while sparing normal brain cells. All oHSVs clinically evaluated so far harbor deletions of the neurovirulence gene γ34.5 for safety. GSCs are not permissive to γ34.5-deficient oHSV replication. In contrast, the non-stem like cell lines isolated from the same GBM tumor as the GSCs are permissive. A suppressor mutation which causes immediate early expression of HSV gene Us11 rescues γ34.5-deficient oHSV replication in GSCs. These observations lead me to hypothesize that GSCs express a unique factor, not expressed in the bulk tumor cells, which blocks γ34.5-deficient oHSV replication. Here I propose using a cell culture system which allows us to observe two different cell populations from the same tumor in order to identify novel factor(s) which inhibit γ34.5-deficient oHSV replication. This proposal seeks to identify GSC restriction factor(s) and characterize the HSV-1 Us11 protein's structural functionality in regards to antagonizing these factor(s).

Public health relevance
PUBLIC HEALTH RELEVANCE: This project aims to identify how glioblastoma stem cells (GSC) are able to inhibit the replication of γ34.5-deficient oncolytic herpes simplex virus-1 (oHSV). The project will first identify when the lifecycle of oHSV is interrupted in GSCs, and whether the same interruption occurs in other stem-like tumor cells. Next this proposal aims to identify which domains of HSV protein (Us11) are responsible for rescuing γ34.5-deficient HSV replication in GSCs and identifying the cellular factor(s) responsible for blocking the virus' replication by using mass spectrometry and shRNA knock down.